Molecular physiology of intracellular InsP3R and MCU ion channels

SUMMARY
Modulation of the cytoplasmic concentration of Ca2+ ([Ca2+]i) by inositol trisphosphate (InsP3)-triggered release
of Ca2+ from the endoplasmic reticulum (ER) is a ubiquitous signaling system that regulates numerous cell
physiological processes. InsP3-mediated [Ca2+]i signals are manifested as repetitive spikes or oscillations, and
they can be highly localized or propagate to provide signals to discrete parts of the cell. At the heart of this
complex signaling system is the InsP3R ion channel. We have provided rigorous understanding of the ion-
channel properties of the InsP3R, by studying the channel using powerful quantitative single-channel patch-
clamp electrophysiology of native ER membranes, a technique that we pioneered; how those properties are
regulated by physiological agonists and protein interactions; and how changes in these properties are reflected
in physiological outcomes. An important physiological target of InsP3R-mediated Ca2+ signals are mitochondria.
InsP3R channels play a fundamental role in the regulation of cell metabolism, primarily by supplying released
Ca2+ to mitochondria to stimulate TCA-cycle dehydrogenases to promote oxidative phosphorylation (OXPHOS)
and ATP production. We discovered that low-level constitutive InsP3R-mediated Ca2+ release to mitochondria
is essential for maintaining basal levels of OXPHOS and ATP production in most cell types, and that cancer
cells have a particular reliance on this pathway for their survival. The primary pathway for mitochondrial Ca2+
uptake is the mitochondrial Ca2+ uniporter (MCU), a Ca2+-selective ion channel in the inner mitochondrial
membrane (IMM). As for the InsP3R, we have employed biochemical and powerful biophysical approaches to
understand the ion-channel properties of MCU, including patch-clamp electrophysiology of MCU Ca2+ currents
in individual mitoplasts. Our overarching effort has been to quantitatively understand the molecular
physiologies of the InsP3R and MCU channels whose integrated activities control cellular physiology and life
and death decisions. Recently, cryo-electron microscopic (cryo-EM) structures of both the InsP3R and MCU
have been solved. Because of our exertise in the biophysics and molecular physiology of these intracellular ion
channels, we are uniquely positioned to exploit this new information to address important questions regarding
the molecular mechanisms of ion permeation and channel gating and their regulation of both Ca2+ ion
channels. Our goals are to understanding the molecular mechanisms of InsP3R channel gating regulation, to
gain fundamental new insights into the molecular mechanisms of MCU channel ion permeation and gating
regulation, including by interacting mitochondrial proteins, and to exploit the information gained from the first
two goals to provide quantitative insights into ER-to-mitochondrial Ca2+ transfer. Because of the fundamental
reliance of cancer cells on this signaling system and its role in familial Alzheimer's disease, we expect that
these studies will provide new and critical quantitative insights into a signaling pathway that is important in
many cell physiological processes.

Public health relevance
NARRATIVE Endoplasmic reticulum (ER)-to-mitochondria Ca2+ transfer mediated by the inositol triphosphate receptor (InsP3R) Ca2+ release channels and the mitochondrial Ca2+ uniporter (MCU) Ca2+ uptake channel, plays important roles in many cell physiological processes. We will use powerful biophysical approaches to study the permeation and gating behaviors of both ion channels in their native membrane environments to provide a detailed understanding of the ion permeation and gating kinetics of both ion channels, providing a quantitative understanding of ER-to-mitochondria Ca2+ transfer in health and disease, including cancer and Alzheimer's disease.